Wake Forest Translational Alcohol Research Center (WF-TARC)

PROJECT SUMMARY
The central goal of the Wake Forest Translational Alcohol Research Center (WF-TARC) is to employ animal
models and human subjects research to study behavioral and neurobiological substrates associated with
vulnerability (and resilience) to alcohol use disorder (AUD). This Center builds on a highly productive
translational alcohol research program at WFSM that was recently established with NIAAA developmental
program project (P01) support.
The WF-TARC will have four research projects and two cores. An administrative core will provide the
leadership and infrastructure needed to ensure integration across all research projects, provide biostatistical
support, and promote interactions and communication between this Center and the many other addiction-
related research and educational programs at Wake Forest School of Medicine (WFSM). A pilot project core
will be established to advance the goals and objectives of the WF-TARC. This core will fund four projects each
year to attract new investigators to bring their talent and expertise to the study of AUD vulnerability.
The unifying research focus of the WF-TARC will be to leverage the strengths and advantages of animal
models and human subjects research to study behavioral correlates of AUD vulnerability and identify
neurobiological adaptations that contribute to this heightened risk of developing AUD. Studies will employ
cutting-edge, multidisciplinary experimental approaches spanning molecular, cellular, circuit, and whole-brain
analyses. Importantly, each project will evaluate novel interventions targeted at the reversing the maladaptive
neural adaptations that promote AUD vulnerability. The highly-integrated conceptual framework and research
design will facilitate backward and forward interactions between the projects, facilitating the rapid translation of
therapeutic discoveries from animals to humans.
The WF-TARC takes advantage of a well-established, extremely collaborative translational alcohol research
program at WFSM and will benefit from a strong and growing institutional focus on alcohol and drug addiction
research. This Center will further enhance the outstanding educational environment at our institution, providing
unique training opportunities for the students and postdoctoral who will become the next generation of
translational alcohol researchers. Finally, the innovative research that will be supported by the WF-TARC may
lead to better evidence-based therapies for individuals who are at greatest risk of developing AUD, individuals
who are particularly ill-served by current AUD treatment options.

Public health relevance
PROJECT NARRATIVE The overarching research focus of the Wake Forest Translational Alcohol Research Center is to study behavioral correlates associated with heightened vulnerability to alcohol use disorder and identify neurobiological adaptations responsible for these behaviors. The highly integrated experimental design leverages the unique benefits of rodent, non-human primate and human subjects research to facilitate backward and forward translation between projects. Collectively, these studies may lead to novel therapeutic interventions for individuals at greatest risk of developing alcohol use disorder.